Long non-coding RNA MCRL1 regulates human cardiac and hematopoietic differentiation via interacting with β-Catenin

PROJECT SUMMARY
Mesoderm specification is a critical event at the gastrulation stage of embryogenesis, ultimately giving rise to
various mesoderm-derived tissues, including blood and heart. Over the past decades, mechanistic studies on
mesoderm specification have predominantly centered on conserved genes, such as transcription factors,
epigenetic regulators, and signaling pathways. Particularly, Wnt/β-Catenin pathway critically contributes to the
induction of mesodermal cells towards cardiac and hematopoietic fate during gastrulation. However, the
existence of human-specific molecular mechanisms underlying mesoderm specification remains enigmatic.
Recently, accumulated evidence underscored the essential roles of long non-coding RNAs (lncRNAs) in human
cardiovascular development, metabolism, and disease. Using human embryonic stem cells (hESCs) to
recapitulate human cardiogenesis, we identified a novel human lncRNA HBL1, which is highly expressed in
hESCs and critically regulates human cardiogenesis (Dev Cell 2017,4:333-8; Development 2021.13: dev199628).
In this proposal, we discovered another novel human lncRNA termed Mesoderm Commitment Regulatory
LncRNA 1 (MCRL1). MCRL1 is a 735bp nuclear lncRNA conserved in non-human primates but absent in rodents.
During cardiac differentiation from hESCs, MCRL1 transiently expresses in the mesoderm precisely at the
mesoderm specification stage. Notably, MCRL1 deficiency (MCRL1KO) does not affect mesoderm formation, but
prominently switches mesoderm specification from cardiac to hematopoietic fate. Transgenic overexpression of
MCRL1 in mouse mesoderm leads to embryonic lethality with enlarged heart. Intriguingly, MCRL1 oppositely
modulates β-Catenin occupancy on cardiogenic and hematogenic genes. Furthermore, MCRL1-β-Catenin
interaction repressed BMI1, a crucial subunit of the PRC1 epigenetic complex. BMI1 ablation in MCRL1KO hESCs
restored the aberrant cardiac and hematopoietic commitment from MCRL1KO mesoderm. Thus, we hypothesize
that MCRL1 plays a pivotal role in human mesoderm specification towards cardiac and hematopoietic fates by
modulating β-Catenin downstream gene expressions at both transcriptional and epigenetic levels. Two specific
aims are outlined. Specific Aim 1. Deciphering the transcriptional mechanisms governed by MCRL1-β-Catenin
interaction in regulating mesoderm specification. Specific Aim 2. Investigating the epigenetic mechanisms driven
by the MCRL1-β-Catenin→BMI1 axis in modulating mesoderm specification.

Public health relevance
PROJECT NARRATIVE Fate specification of mesoderm is a crucial step in mammalian embryogenesis. To date, human-specific molecular mechanisms that govern human mesoderm fate specification remain largely elusive. This proposal offers a comprehensive framework for investigating the pivotal role of the long-non-coding RNA MCRL1 in human mesoderm fate specification and its implications for cardiac and hematopoietic differentiation.